Core B Research Development

CORE B: RESEARCH DEVELOPMENT - SUMMARY/ABSTRACT
The Research Development Core B provides support for Pilot Projects for the advancement of geroscience
research. In general, most of this pilot support is granted to junior investigators but applications from senior
faculty who wish to enter the field will be considered. The vast majority of awards will be targeted to candidates
outside our region. We will have three categories of awards: 1) Those that utilize the Core Resources of the UW
Nathan Shock Center; 2) Pilots that facilitate the integration and interaction between Cores; and 3) Pilots that
support projects geared towards under-represented groups, specifically students who wish to be expose to the
Biology of Aging as a research career. These awards will provide fully subsidized access to our Resource Core
services, necessary reagents and supplies, statistical support at every stage of the project, and mentoring by a
senior faculty member. This activity is directed by the Core Leaders in concert with the Executive Committee of
our Nathan Shock Center. Core B will also be responsible for the advertising and reviewing and reviewing of
pilot applications; the administrations of the awards; and the for mentorship and monitoring of individuals who
will be selected for these positions. Our record of past performance has shown that these pilot awards are integral
in the support for investigators embarking on new projects in the Biology of Aging that may not yet have achieved
outside funding.